Mitochondrial calcium uptake in Alzheimer’s disease

Abstract:
Alzheimer's disease (AD) is characterized by the loss of memory accompanied by neuronal cell death and
metabolic dysfunction. Numerous studies have reported a dysregulation in neuronal intracellular calcium
(1Ca2+) signaling as an early event in AD pathogenesis. It is thought that a prolonged elevation in neuronal 1Ca2+
promotes excessive mitochondrial calcium (mCa2+) uptake, yet to date no study has examined the contribution
of mCa2+ uptake to disease progression. Since mCa2+ flux is an important regulator of cellular respiration and
cell death, both of which are involved in AD pathogenesis, we hypothesize that mCa2+ overload is a key
contributor to AD pathology and may contribute to metabolic deficits and neuronal demise. To define the role of
mCa2+ exchange in AD we have generated 3xTg-AD mutant mice with neuronal-specific deletion of
Mitochondrial Calcium Uniporter (MCU), which is required for mCa2+ uptake. In addition, we have generated a
gain-of-function mutant mouse expressing the recently identified mitochondrial calcium uniporter beta subunit
(MCUb). MCUb was recently reported as a negative regulator of mCa2+ uptake and we have observed
substantial changes in its expression in AD. These models will allow causative experimentation to test if mCa2+
uptake drives AD progression. Mice will be examined for alterations in memory, amyloidosis, tau-pathology,
oxidative stress, synaptic and metabolic function. Preliminary data suggest that mCa2+ uptake overload impairs
the clearance of misfolded proteins and dysfunctional mitochondria. Therefore, we will mechanistically examine
the link between mCa2+ exchange and autophagic and mitophagic pathways. Optimally, the proposed studies
will discover new therapeutic targets for AD and associated mitochondrial dysfunction and provide a training
and research platform to promote the Pis independent research career.

Public health relevance
Narrative: Alzheimer's disease is a major age-related pathology in the US with an estimated medical cost of $277 billion in 2018. We hypothesize that mitochondrial calcium exchange pathways contribute to AD progression and that understanding these signaling pathways will yield new therapeutic approaches.